Aerosol delivery of combinational therapeutics targeting deadly lung infections

Project Summary/Abstract
Pulmonary infections caused by multidrug-resistant bacteria are extremely difficult to treat. Gram-negative
`superbugs' are particularly worrisome in pulmonary infections and are often only susceptible to polymyxins.
However, intravenous polymyxins have poor efficacy for pulmonary infections due to limited drug exposure in
the airway. Inhaled polymyxins have been increasingly used in the clinic for the treatment of pulmonary infections;
yet current inhalation therapies are empirical and have never been optimized using
pharmacokinetics/pharmacodynamics/toxicodynamics approaches. No systematic evaluations have ever been
conducted on the pulmonary toxicity of inhaled polymyxins. Furthermore, the currently used traditional jet
nebulization has very low delivery efficiency (<15% of drug delivered to the lungs). Suboptimal use of inhaled
polymyxins has caused unsatisfactory therapeutic efficacy, emergence of resistance, frequent adverse effects,
and poor patient compliance. We have elucidated that polymyxin-induced pulmonary toxicity involves drug
accumulation in human alveolar epithelial cells, particularly in mitochondria, which leads to oxidative stress,
mitochondrial damage and apoptosis. Excitingly, we discovered that polymyxin combinations with
aminoglycosides can significantly attenuate polymyxin-induced pulmonary toxicity, maximize antimicrobial
activity and prevent resistance development. In this proposal, we will employ a multi-disciplinary approach to
develop efficient powder aerosol delivery systems for these promising polymyxin combinations. The overarching
hypothesis is that our optimized aerosol therapy of polymyxin combinations possesses superior delivery
efficiency and PK/PD/TD to treat pulmonary infections; prevents bacterial resistance by synergistically inhibiting
multiple key biochemical pathways; and minimizes toxicity in lung epithelial cells. The specific aims are: (1) To
elucidate the mechanisms of attenuation of polymyxin-induced pulmonary toxicity by aminoglycosides using
advanced imaging, CRISPR and transcriptomics; (2) To develop efficient aerosol delivery systems of polymyxin
combinations using innovative manufacturing techniques; (3) To examine the tripartite relationships among
human lung cells, Gram-negative pathogens, and superior polymyxin combinations using correlative multi-omics;
and (4) To optimize the dosage regimens of superior inhaled polymyxin combination formulations using a
machine learning-driven mechanism-based PK/PD/TD model. Our project responds in a timely manner to the
recent National Action Plan for Combating Antibiotic-Resistant Bacteria (2020 – 2025).

Public health relevance
Project Narrative Public Health Relevance Statement: Lung infections caused by Gram-negative `superbugs' is very difficult to treat due to the resistance to almost all current antibiotics except polymyxins. Inhaled polymyxin therapies have been increasingly used as the last resort globally; however, the lack of appropriate delivery system and dearth in pharmacological information have led to insufficient efficacy and pulmonary adverse effects. Our multi- disciplinary project will develop innovative aerosol delivery systems of polymyxin combinations with cutting-edge technologies to provide much safer and efficacious treatments for deadly Gram-negative lung infections.